Protection Against Nosocomial Infections After Severe Burn Injury Through Trained Immunity

Research Experience Plan
Abstract of Funded Parent Award R35 (GM141927; PI: Julia Bohannon; Funding Period: 5/1/2021-4/30/2026)
Nosocomial infections remain the leading cause of death in severely burned patients due to barrier loss, impaired
immunity, and high prevalence of antibiotic resistant pathogens. Immunomodulatory strategies aimed at augmenting the
host response are greatly needed. Evidence suggests that Toll-like receptor (TLR) agonists hold strong promise as
immunotherapeutic agents to achieve that goal. Priming with TLR4 agonists enhances resistance against a variety of
clinically relevant infections associated with severe burn injury in mice via induction of “trained immunity” whereby
innate immune cells become more responsive to subsequent infectious stimuli. TLR4-mediated trained immunity is
characterized by metabolic reprogramming and mitochondrial expansion in macrophages which boost antimicrobial
responses. Cellular signaling mechanisms responsible for TLR-mediated trained immunity and the effect of burn injury on
metabolic and mitochondrial function in innate leukocytes remains to be elucidated. Our research program aims to
investigate immunomodulatory therapies for prevention of infection following severe burn by elucidating burn-induced
immunometabolic dysfunction and the potential for triggering trained immunity for protection after burn. To achieve these
goals, we will pursue three integrated projects: Project 1 will investigate the impact of severe burn and post-burn infection
on myeloid cell immunometabolism and mitochondrial function. We will assess metabolic, mitochondrial, and
antimicrobial function using a variety of techniques including glycolytic and oxidative stress capacity, mitochondrial
content and function analyses, and differential gene expression in mouse and human leukocytes after burn. This project
will expand our understanding of molecular mechanisms behind burn-induced leukocyte dysfunction. Project 2 will
evaluate mechanisms by which TLR agonists induce trained immunity in leukocytes after burn. We will use genetic
modification, TLR signaling pathway-selective agonism, and signaling pathway blockade to investigate the molecular
mechanisms involved in TLR-mediated induction of trained immunity after burn. We will examine the ability of TLR
agonists to induce trained immunity in leukocytes from burn patients. This project will fill critical gaps in our
understanding of mechanisms by which we can improve resistance to infections in burn patients. Project 3 will elucidate
the potential of targeting TLR-signaling pathways for therapeutic benefit in clinically relevant models of burn-associated
infection. We will determine the efficacy of clinically applicable TLR agonists in conferring protection against a variety of
pathogens prevalent in burn patients. We will evaluate protection duration, extension of protection upon repeated therapy,
and whether TLR agonists can promote infection clearance after infection onset. This project will reveal potential drug
targets that should be considered for clinical development for mediating protection against nosocomial infections in burn
patients. These projects will enhance our understanding of burn-induced innate immune dysfunction and identify
therapeutic targets to improve immunity and protect against burn-related infections.